Mechanisms of mGluR5 function and dysfunction in mouse autism models

DESCRIPTION (provided by applicant): Fragile X Syndrome (FXS) is the most common, inherited form of intellectual disability and the leading genetic cause of autism 21, 160-164. Transcriptional silencing or loss of function mutations of a single gene, Fmr1, lead to FXS165. Fmr1 encodes a neuronal RNA binding protein, Fragile X Mental Retardation Protein (FMRP) 6. Accumulating evidence indicates that the Gq-coupled metabotropic glutamate receptor 5 (mGluR5) is dysfunctional and overactive in the mouse model of FXS, Fmr1 KO mice 26, 28, 29, 34, 56. Consequently, mGluR5 antagonists reverse many of the phenotypes in FXS animal models and are currently in clinical trials in FXS patients 30, 31, 33-38, 108. The cellular mechanisms of mGluR5 dysfunction in Fragile X have been elusive. A clue comes from the findings that mGluR5 is less associated with the synaptic scaffolding molecule Homer in Fmr1 KO mice 14. The N-terminal EVH1 domain of Homer binds to the C-terminus of mGluR5 as well as signaling effectors, ion channels, and other synaptic scaffolds. The C-terminal coiled-coil domain of Homer dimerizes with other Homer molecules to scaffold mGluR5 to its effectors and the postsynaptic density. A short variant of Homer, Homer1a, lacks the coiled-coil domain, disrupts long Homer scaffolds, which in turn, alters mGluR5 signaling, subcellular localization and causes agonist-independent activity of mGluR5 42, 43, 105, 137, 140, 166, 167. We find that the disrupted mGluR5-Homer interactions mediate much of the altered mGluR5 function as well as the neurophysiological and behavioral phenotypes of Fmr1 KO mice 13, 44. It is unknown if FXS results from a specific disruption in mGluR5-Homer interactions or a disruption of Homer scaffolds in general. To test these ideas, we will determine if Homer interactions with other proteins are affected in Fmr1 KO mice and if a transgenic mouse expressing a knockin mutation of mGluR5 (F1128R) that does not interact with Homer is sufficient to mimic the biochemical, neurophysiological and behavioral phenotypes of Fmr1 KO mice 45. It is unknown what leads to reduced mGluR5-Homer interactions in Fmr1 KO mice. Phosphorylation of mGluR5 20, 46, 47 and Homer at specific sites are known to regulate their interactions . In Aim 2, we will determine if mGluR5 and Homer phosphorylation are altered in Fmr1 KO mice and examine candidate mechanisms for this altered phosphorylation. FMRP functions to translationally suppress its mRNA targets, which leads to elevated levels of specific proteins in Fmr1 KO mice 6. In Aim 3, we will determine if elevated levels of a candidate protein in Fmr1 KO mice, known to interact with mGluR5, results in altered mGluR5 function and Homer scaffolds in Fmr1 KO neurons 15, 16. In Aim 4, we will examine another mouse model of autism to determine if altered mGluR5 function and disrupted mGluR5-Homer scaffolds constitute shared neurobiological mechanisms of autism and FXS 19, 51. Results of this work are expected to determine the core molecular deficits of FXS and autism and provide novel targets for pharmacological intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: Excessive mGluR5 activity has been proposed to cause mental retardation and autism associated with Fragile X Syndrome. Here we propose to determine the cellular mechanisms for altered mGluR5 function in Fragile X Syndrome and to determine if altered mGluR5 function is a common cause of autism. Excessive mGluR5 activity has been proposed to cause mental retardation and autism associated with Fragile X Syndrome. Here we propose to determine the cellular mechanisms for altered mGluR5 function in Fragile X Syndrome and to determine if altered mGluR5 function is a common cause of autism. __SpecificAimsTextDelimiter__ Specific Aims: Fragile X Syndrome (FXS) is the most common inherited form of mental retardation and a leading genetic cause of autism. We first discovered alterations the Group 1, Gq coupled metabotropic glutamate receptor 5 (mGluR5) function, and plasticity in the mouse model of FXS, a knockout of Fmr1, the gene mutated in FXS. Our findings motivated studies demonstrating that mGluR5 antagonists are successful in reversing symptoms in FXS animal models. Hence, mGluR5 blockers are now in Phase 2 clinical trials in patients. It is unclear how or why mGluR5 is dysfunctional in FXS, how mGluR5 dysfunction mediates FXS phenotypes. One substantiated hypothesis is that Fmr1 regulates protein translation downstream of mGluR5 (Fig. 1B)6. We have now discovered a second, major mechanism of mGluR5 dysfunction in Fmr1 KO mice - altered association of mGluR5 with the scaffolding protein Homer (Fig. 1A) - and our data suggests that these 2 mechanisms of mGluR5 dysfunction mediate distinct neurological impairments in FXS. In this proposal, we focus on the latter- the role of altered mGluR5-Homer scaffolds in FXS and autism. The Homer family of proteins binds to the intracellular C-terminal tail of group 1 mGluRs and form multi- protein signaling complexes at the postsynaptic density with mGluRs and their downstream effectors 7, 8. All Homer isoforms (Homer 1-3) share a common EVH1 domain at the N-terminus, which binds to mGluR1, mGluR5, PI3 Kinase enhancer (PIKE), IP3 receptor, SHANK and others9-12. Homers multimerize through their coiled-coil domains and scaffold mGluRs to signaling pathways8 and localize mGluRs to the postsynaptic density. An activity-dependent, short, variant of Homer, Homer1a, (H1a) lacks a coiled-coil domain, and disrupts Homer scaffolds by competing with long Homers for mGluR5 and other Homer interacting proteins. Interestingly, H1a results in constitutive, agonist-independent activity of mGluR5. In Fmr1 KO mice mGluR5 is less associated with long Homer isoforms and more associated with H1a14. Remarkably, genetic deletion of H1a restores mGluR5-Homer scaffolds and corrects multiple phenotypes in Fmr1 KO mice (Figs. 2-4). Furthermore, acute, peptide-mediated disruption of mGluR5-long Homer scaffolds in wildtype brain mimics phenotypes of the Fmr1 KO. Therefore, many biochemical, neurophysiological and behavioral phenotypes in Fmr1 KO mice are due to a shift in the balance of short and long Homers bound to mGluR5 (Figs. 2-4). The mechanisms that lead to decreased mGluR5-Homer scaffolds interactions in FXS are unknown. Furthermore, it is unknown how altered mGluR5-Homer scaffolds lead to FXS symptoms or if their altered interaction contributes to more broadly to autism and cognitive dysfunction. Here we propose experiments to address these questions in the following specific aims: Specific Aim 1: Are Fragile X Syndrome phenotypes caused by a specific deficit in mGluR5-Homer interactions and constitutively active mGluR5? H1a results in constitutive, agonist independent activity of mGluR5 (mGluR5CA) and inverse agonists that block mGluR5CA rescue many Fmr1 KO phenotypes. Here we will determine if mGluR5CA occurs in Fmr1 KO neurons. We will also determine if a knockin mouse with a mutated mGluR5 (F1128R) that does not interact with Homer and is constitutively active mimics the mGluR5 dysfunction, neurophysiology and behavior of Fmr1 KO mice. Specific Aim 2: Determine if phosphorylation of mGluR5 or Homer contributes to decreased Homer scaffolds in Fmr1 KO mice. Here we will examine the phosphorylation state of mGluR5 and Homer in Fmr1 KO mice. Preliminary data indicate that Homer phosphorylation is increased in Fmr1 KO mice at sites known to decrease interactions with mGluRs and other binding partners (Thr36 and S120). We will also examine Homer complexes with other interacting proteins and test the contribution of candidate kinases to Homer phosphorylation and mGluR5 dysfunction in Fmr1 KO mice. Specific Aim 3: Determine if loss of FMRP-mediated translational control of Amyloid Precursor Protein leads to decreased mGluR5-Homer interactions. FMRP interacts with the mRNA for Amyloid precursor protein (APP) and levels of APP and its cleavage product A peptide are increased at Fmr1 KO mouse synapses 15. A directly interacts with mGluR516 and genetic reduction of APP may reverse mGluR5 dysfunction in Fmr1 KO mice (Fig. 7). Here we will test the hypothesis that FMRP loss leads to an increase in APP and A levels, which alter mGluR5-Homer interactions and mGluR5 dysfunction. Specific Aim 4: Determine if alterations in mGluR5-Homer function contribute to other autism models. Loss of function mutations in Phosphatase and tensin homolog deleted on chromosome 10 (PTEN) lead to increased PI3K and AKT activity and autistic behaviors 17-19. AKT phosphorylates Homer and decreases its interaction with binding partners 20. We hypothesize that mGluR5 dysfunction, as a result of decreased mGluR5-Homer interactions, contributes to other genetic causes of autism. To test this, we will examine mGluR5 Homer interactions and mGluR5 function in the PTEN KO mouse autism model and determine if genetic reduction of mGluR5 or deletion of Homer1a reverses key phenotypes in these mice.